Structural and functional investigations of two lysosomal transporters implicated in developmental disorders

PROJECT SUMMARY
Lysosomal storage diseases (LSDs) comprise a group of over 70 inherited autosomal recessive disorders that
are caused by malfunctions in lysosomal proteins, leading to a buildup of specific substrates in the lysosome.
These relatively rare disorders tend to manifest in infants, although adult forms also exist. Cystinosis and Infantile
Sialic acid Storage Disease (ISSD) are two of the more common LSDs. Symptoms of Cystinosis include renal
and vision problems, while symptoms of ISSD include problems with the central nervous system and early death.
Both of these genetic disorders also cause severe developmental delay. Cystinosis is caused by mutations in
the protein Cystinosin, a lysosomal H+:cystine symporter, while ISSD is caused by mutations in the protein Sialin,
a lysosomal H+:sialic acid symporter and neurotransmitter uniporter. Structural and functional data will help shed
light on the exact molecular mechanism by which disease mutations affect the function of these proteins. In my
preliminary studies, I generated a structurally specific monoclonal antibody that recognizes the luminal domain
of Cystinosin, Fab3H5. Using this antibody, I solved three structures of human full-length Cystinosin: an outward-
facing apo conformation at 3.4-Å resolution at pH 7.5, an inward-facing apo conformation at 3.2-Å resolution at
pH 5.0, and a cystine-bound conformation at 3.4-Å resolution. These structures revealed the residues involved
in the cytosolic and luminal gates that mediate the transport of its substrate cystine, as well as the residues that
interact with cystine in the binding pocket of Cystinosin. Preliminary electrophysiological data for this protein
further identified mutations D205N and D305N, which abolished transport, and mutations Q284A and D346N,
which maintained a transport activity similar to the wild-type protein. In order to fully define the molecular
mechanism of transport for Cystinosin, I propose to solve the structure of these Cystinosin mutants and test
them with electrophysiological assays, building a more complete picture of the binding and transport mechanism.
With reference to Sialin and ISSD, my preliminary work has yielded a monoclonal antibody; however, the 3D
reconstruction of Sialin with this antibody did not yield visible secondary structures. Therefore, I will first optimize
the antibody screening process. This will allow me to isolate a structurally specific monoclonal antibody that I
can use for structural studies. I will then solve the structure of Sialin using the same general approach that has
been successful with Cystinosin. Since Sialin is also a H+:sialic acid symporter, different pH environments will
be used to capture different conformations. Sialin also binds and transports various substrates. Therefore, I will
also solve the substrate-bound structures of Sialin, thus providing more information about the binding pocket(s)
of the substrates. Important mechanistic and substrate binding residues will then be tested via electrophysiology
(for sialic acid) and radiolabeled substrate uptake assays (for neurotransmitters). These proposed studies will
reveal the underlying molecular mechanisms behind the LSDs Cystinosis and ISSD, paving the way for further
translational research and therapeutic design.

Public health relevance
PROJECT NARRATIVE Membrane transporters Cystinosin and Sialin are implicated in lysosomal storage diseases that manifest in infants, affecting various systems of the body and causing severe developmental delays. The proposed research will elucidate the molecular mechanism of these two proteins through structural determination and functional testing of important residues. The resulting insights into how these proteins bind and transport their various substrates will provide a basis for future development of therapeutics to treat their associated diseases.